SCIENTIFIC AND TECHNICAL SUPPORT SERVICES (STSS) PROGRAM SUPPORT

Shared collaborative cloud environment, including cloud-based productivity tools, a service desk, commercial and open-source deployments of analytical tools for the Clinical and Translational Science Awards program.